INHIBITION OF 1,25-DIHYDROXYVITAMIN D SYNTHESIS BY KETOCONAZOLE

The anti-fungal agent ketoconazole has been shown to inhibit 1,25-dihydroxy Vitamin D synthesis. It will be used in this study as a probe to study nephrolithiasis patients with absorptive hypercalciuria to determine whether or not their increased intestinal calcium absorption is Vitamin D dependent.